The OUD Cascade of Care and Critical Outcomes: Longitudinal Linkage with Opioid Use

The OUD Cascade of Care and Critical Outcomes: Longitudinal Linkage with Drug Use
Dramatic increases in overdose deaths in the US have created an urgent need to improve access to
and retention in evidence-based care for opioid use disorder (OUD) with medication (MOUD), under the OUD
Cascade of Care framework. The Cascade model emphasizes key stages or transitions during the treatment of
individuals with OUD to reduce risks of adverse outcomes: critically, successful MOUD initiation and long-term
retention. However, it has thus far been agnostic towards concurrent opioid use. In the era of rising fentanyl
prevalence in the illicit drug supply, public health frameworks need to adjust for environmental conditions that
may impact clinical outcomes. Our research approach draws from a conceptualization of opioid use, treatment
response, and adverse outcomes as evolving along trajectories, over varying timeframes emphasizing the
need for harm reduction approaches tailored to patient goals as they evolve over time. While we hypothesize
that greater exposure to fentanyl in the local drug supply will impede successful treatment engagement, we
also expect longer durations of buprenorphine treatment to protect against overdose risk, even among patients
with intermittent opioid use while in care. However, patients with opioid use in care will likely experience
attenuated risk reductions following treatment discontinuation.
There is a critical need for longitudinal analyses of treatment pathways and outcomes, including the
intersecting roles and prognostic significance of toxicology results and treatment retention, and their
relationship to overdose risk during and following treatment. Because current evidence concerning optimal
durations of care, especially at the individual patient or sub-population level, is lacking, there is currently little
empirical evidence to guide clinicians and health systems regarding how to best tailor service provision and
estimate risks of adverse events at the patient level. Our proposal seeks to fill these critical gaps in knowledge.
We will link EHR records for 95,000 individuals from a multi-state buprenorphine provider-- the nation’s
largest OBOT provider-- with Medicaid claims and National Death Index (NDI) data to create a new, unique,
integrated database spanning 2014-2022 in a dozen states to observe patients before intake, at baseline, and
while in care over multiple years, accounting for mortality during the onslaught of fentanyl. Medicaid is now the
largest payer for MOUD. Our findings will have broad implications for clinical care, policy, systems design,
quality measurement development, and healthcare administration. Our goal is to establish an empirical
evidence base to inform clinical evaluations of patient risks (e.g. adverse outcomes including overdose) at the
individual level. Against the scale and gravity of the evolving opioid epidemic, it is vital that clinical and policy
strategies are informed by careful consideration of rigorous analyses of empirical data with large, usual-care
populations across state lines.

Public health relevance
Project Narrative: Deaths due to the opioid crisis have been driven in large part by low rates of successful initiation and retention of patients with opioid use disorder (OUD) on medication treatment (MOUD) as most drop out of care within a few weeks or months. Risks are only greater in an era of increasing fentanyl penetration. We propose to create a unique and highly powered dataset by linking the electronic health records (EHR) from the nation’s largest buprenorphine provider in a dozen states that uses a unified EHR across sites for ~95,000 patients, with CMC Medicaid insurance claims and CDC National Death Index data. We will examine patterns of opioid use while in care and critical outcomes such as emergency department visits, overdose, and death following long-term episodes of care to inform clinical decision support tools and risk prognosis to transform clinical practice and guide quality measure development and system design.